SOLUTION STRUCTURE DETERMINATION USING NMR 2D NOE DATA OF DNA OLIGONUCLEOTIDES

We are currently involved with method development and the application of these methods to find solution structures of macromolecules using a combined NMR and molecular dynamics. We are applying the methods in the study of the B-DNA duplex mismatch sequence d(CGCGATTCGCG) and of the hairpin loop form of the oligodeoxyribonucleotide, d(GCGCTTAGCGC). These methods are also being used in looking for the solution structure for the B-DNA "Dickerson" dodecamer d(CGCGAATTCGCG) with perhaps the best NMR data available to data on this system. The NMR data for this system is not consistent with the structure determined by X-ray crystallography.